Brown University Community and Clinical Research Training Program

SUMMARY
This is a competitive renewal application for the Brown University Community and Clinical Research Training
Program, currently funded through NIMH R25MH083620. Our goal is to train the next generation of researchers
to end the HIV epidemic and to conduct research related to reducing racial disparities in HIV outcomes in the
Southern United States. This renewal application is led by Dr. Amy Nunn and Dr. Leandro Mena, who have
worked collaboratively on these topics for over a decade in Mississippi and beyond. This program was initially
funded in 2008 and exceeded its key objectives during the last 11 years; we trained 40 investigators during the
last funding cycle. During the last five years, our fellows attributed 492 peer reviewed articles and 53 successfully
funded grants to this training program. This renewal application continues our focus on racial disparities and
community engaged scholarship, with greater emphasis on ending the epidemic in the South and in jurisdictions
most heavily impacted by the HIV epidemic. This initiative and the mentoring curriculum will align with the
US Plan to End the HIV Epidemic (EtHE). The program will prioritize training investigators from communities
historically underrepresented in the sciences, with emphasis on training investigators from or conducting
practice-oriented research in geographic hotspots of HIV infection, with a focus on the South. This structured
mentoring program will focus on community-engaged scholarship, geographically circumscribed interventions,
reducing racial disparities in HIV infection, partnering with health departments, and delivering proven HIV
prevention and care interventions through novel means in the rural South. The program has the following specific
aims: Specific Aim 1: To train the next generation of researchers in the communities most heavily impacted by
the epidemic in HIV/AIDS research to develop, implement, and evaluate interventions to reduce racial disparities
in HIV prevention and care, including HIV screening, PrEP, and HIV treatment. This training includes formal
coursework, quarterly mentoring workshops, one-on-one mentoring, epidemiological design, and clinical service
delivery experiences in real-world clinical and community settings. Specific Aim 2: To train investigators from
communities enumerated in the EtHE plan, particularly African Americans and Hispanic/Latinos in the South.
These investigators will lead scientific investigation addressing social, structural and behavioral drivers of the
epidemic; lead clinical, epidemiological and implementation research to mitigate HIV/AIDS disparities; and
develop, implement, and evaluate culturally appropriate and geographically circumscribed interventions focused
on the South.

Public health relevance
NARRATIVE This is competitive renewal application for the Brown University Community and Clinical Research Training Program currently funded through NIMH R25MH083620. This structured mentoring program will focus on community-engaged scholarship, geographically circumscribed interventions, reducing racial disparities in HIV infection, and delivering proven HIV prevention and care interventions through novel means in the rural South.